Polymeric nanoassemblies for precise tuning of immune responses

PROJECT SUMMARY/ABSTRACT
Inflammation is a powerful, multifactorial host defense mechanism intended to protect the body from microbial
insult and tissue damage. As such, inflammation is not only essential to the maintenance of homeostasis but is
on its own deleterious when regulatory mechanisms go awry. Aberrant immune activation is prominent in
human diseases and can contribute to the development of inflammatory (e.g. sepsis), autoimmune, and
allergic conditions for which there are limited therapeutic options available that address the underlying immune
dysfunction. The overarching goal of my research program is to elucidate fundamental and functional
relationships between nanoparticle designs and biological responses in the context of inflammatory
conditions. Indeed, nanoparticles can be designed with inherent immunomodulatory properties that can limit
the extent of the inflammatory response through non-specific or antigen-specific mechanisms. Our group has
made significant strides in both of these areas where we have shown that our custom-designed nanoparticles
could blunt non-specific proinflammatory responses induced by multiple Toll-like receptor agonists in the
absence of additional therapeutic agents. It was further demonstrated that these cargo-less nanoparticles
improved survival in lethal mouse models of LPS-induced endotoxemia to 70%. Encapsulation of peptide or
protein antigens into tolerogenic nanoparticles (tNPs) allows for the specific delivery of antigens to innate
immune cells. Through manipulation of innate immune cell antigen presentation to T cells, the activation of
antigen-specific T cells and disease progression was halted. tNPs were recently evaluated in a Phase I and II
clinical trial for the treatment of celiac disease with success. The rapid progression of nanoparticles
towards clinical implementation highlights the urgent need for mechanistic studies to elucidate the
underlying principles that govern nanoparticle-based immunomodulation. We aim to address this need
by capitalizing on our expertise in nanoparticle design and immune engineering, which includes polymer
synthesis, nanoparticle formulation, and immunology. Over the next five years, we will specifically focus on
how the physical and chemical properties of nanoparticles affect multiple outcomes associated with
inflammatory responses using clinically-relevant in vitro and in vivo models of sepsis, autoimmunity, and
allergy. The outcomes of these studies will enable us to establish a set of design rules that govern the
immunomodulatory activity and interactions of nanoparticles and the immune system to guide the development
and clinical translation of novel nanoparticles for inflammation and antigen-specific disease intervention.
Through successful realization of our program, we will not only contribute to our understanding of the
properties that are necessary for nanoparticles to interact with and internalize into immune cells but also
develop a set of design rules that govern nanoparticle-based immunomodulation, which will have immediate
therapeutic value suitable for future translational applications.

Public health relevance
PROJECT NARRATIVE Inflammation is exquisitely linked to the pathogenesis of immune-mediated conditions. Nanoparticles have risen as a novel strategy to manipulate immune cell responses through multiple biochemical pathways and non-specific and antigen-specific mechanisms. The central vision of my research program is to systematically evaluate the cellular and molecular mechanisms affected by nanoparticles in the context of sepsis (non- specific) and autoimmunity (antigen-specific) to develop fundamental and functional relationships between their physicochemical properties and generated immune responses to ultimately guide the future development of novel therapeutics.